Brain charts of sex as a biological variable for precision structural neuroimaging of the psychosis spectrum

PROJECT SUMMARY
Many neuropsychiatric disorders, including psychosis spectrum conditions, display consistent sex-biases
in their clinical presentation and illness course. Yet whether sex and the related process of puberty influence
neurodevelopment—and thus potentially risk or resilience to the disease-processes associated with psychosis—
remains hotly debated. Much of this ambiguity can be attributed to pervasive methodological limitations, such as
small sample sizes and inflexible statistical approaches, that have led to heterogeneous results. This proposal
aims to overcome these limitations by deriving normative growth models from a massive, global dataset of
structural MRIs (n>120k MRIs, 0-100 years), testing the overarching hypothesis that sex, puberty, and age have
interactive effects on neuroanatomy that together are critical for identifying structural phenotypes of psychosis
spectrum symptoms and diagnoses. This approach extends recent “brain charts” literature in several key ways.
Aim 1 will (1) use brain charts to quantify how sex-differences in neuroanatomy vary across the lifespan, then
apply these normative models to (2) benchmark sensitive biomarkers of schizophrenia-spectrum disorders and
(3) explore how these disease effects differ in males and females. Aim 2 will (1) derive neurodevelopmental
growth charts (n>15k MRIs, 5-25 years) that deliniate puberty’s relationship with brain structure development
and (2) assess how these pubertal effects align with local transcription of sex-hormone receptor genes. Finally,
these puberty-informed brain charts will be used to (3) uncover whether individuals’ deviations from normative
brain development are associated with psychosis spectrum symptoms. The results of this proposal will
significantly advance the NIH’s objective to understand sex as a biological variable in the context of brain
morphology, identify sensitive structural biomarkers of psychosis spectrum pathology in females and males, and
provide a resource for future studies to contextualize brain structure across the lifespan. The proposal will also
enable the applicant to complete rigorous training in statistical neuroimaging techniques and applications; the
neuroscience of biological sex; psychosis spectrum neurobiology; and scientific communication and leadership.
This research and training will be supported by a team of expert mentors comprised of Dr. Aaron Alexander-
Bloch, Dr. Russell T. Shinohara, Dr. Raquel Gur, and Dr. Armin Raznahan, with additional support from
contributor Dr. Benjamin Risk. The world-class informatics resources, didactic trainings, and intellectual
environment provided by the University of Pennsylvania and the Children’s Hospital of Philadelphia will further
ensure the feasibility of the proposed research and prepare the applicant for a career as an independent
academic researcher.

Public health relevance
PROJECT NARRATIVE Although many neurodevelopmental conditions, such as psychosis, display well-documented sex-biases in clinical course and presentation, the influences of biological sex and puberty on neurobiology and disease phenotypes are unknown. By fitting robust growth charts quantifying the effects of biological sex and puberty on brain structure and utilizing them to uncover biomarkers of psychosis, the current proposal will assess the influence of these factors on disease effects and sensitively describe psychosis-related morphology in females and males. These normative brain charts will also greatly advance our understanding of sex as a neurobiological variable and the neurodevelopmental impacts of puberty, a sex-dependent process implicated in the onset of several psychiatric disorders.